Learned olfactory preferences and estradiol

Project Summary
The brain processes sensory information from the environment which, in turn, guides behavior. In
olfaction, the decision to approach or avoid a stimulus is largely informed by correct assignment of an odor’s
valence, or hedonic value. Furthermore, there are pronounced sex differences in odor valence that appear to be
regulated by gonadal hormones, particularly estrogen. This has been well-characterized in studies involving
ethologically relevant odors such as those that convey sociosexual information. However, there is also evidence
that estrogen’s effects on olfaction are not limited to ethologically relevant odors and, in fact, generalize to odors
that do not convey sociosexual information. It is unknown how the sexually differentiated brain represents odor
valence and how estrogen impacts the formation of odor preferences. Odor valence processing occurs across
olfactory structures. Among these, the olfactory tubercle (OT) stands out as being particularly important for direct
control of odor-guided behavior due to its position within the ventral striatum, which receives modulatory
dopaminergic input from the midbrain that informs decision-making. Work from our lab has demonstrated that
the OT flexibly represents the associative valence of odors. Given the abundant expression of estrogen receptors
in the ventral striatum, including the OT, and the pronounced responsivity of other ventral striatal structures to
estrogen, this proposal seeks to identify the sex-dependent contributions of estrogen in the OT’s representation
of odor valence, and in turn, its effects on odor preference. The proposed work will use behavior, in vivo
electrophysiology, and region-specific pharmacology to test the hypothesis that estrogen enhances the
representation of learned odor valence in the OT and contributes to learned odor preference. In Aim 1, I will
demonstrate the sex-specific impact of local estrogen on the representation of odor valence in the OT. In Aim 2,
I will determine the contribution of brain-derived estrogen to the expression of learned odor preferences. The
findings from this work will ultimately reveal novel insights into the ways in which estrogen modulates olfaction
and specifically, odor valence.

Public health relevance
Project Narrative The results of this proposal will enhance our fundamental understanding of olfaction as well as sex-specific effects of estrogen in the brain. The proposed research is relevant to public health because of its implications for conditions that involve olfactory deficits like Alzheimer’s disease, which manifests differently in men and women.